Maryland EJSCREEN 4.0: Integration of Cumulative Impacts, Structural Racism and Discrimination, and Air Quality to Better Visualize and Assess Environmental Health Disparities

PROJECT SUMMARY. Across the state of Maryland, communities of color and low wealth populations are
differentially burdened by environmental hazards and the cumulative impacts of chemical and non-chemical
stressors and structural factors (including pathogenic infrastructure) that produce environmental health
disparities. This phenomenon is known as environmental injustice. To better identify and characterize
environmental justice (EJ) communities, the Center for Community Engagement, Environmental Justice, and
Health (CEEJH) has worked with its partners to develop Maryland Environmental Justice Screen (MD
EJSCREEN), an environmental justice screening and mapping (EJSM) tool. The current version of MD
EJSCREEN (3.0) has features similar to other national and state-screening tools including
CALENVIROSCREEN and USEPA EJSCREEN, and also some of the same gaps limitations. These gaps
include inadequate or missing indicators to capture factors such as economic justice, energy burdens, social
progress, vulnerability, resilience, distributive justice, and assessment of cumulative impact over time. EJSM
tools do not adequately account for the differential impacts of climate change on EJ communities. Additionally,
these tools fail to acknowledge and characterize the effects of structural racism and discrimination (SRD) –
particularly environmental racism – on exposures and cumulative impacts. Other limitations include outdated,
disaggregated data or data that exists at too coarse of a geographic level to identify communities experiencing
cumulative impacts and to micro-target interventions. This particularly relates to air quality data, with infrequent
data updates leading to non-representative characterization of air quality conditions and thus inaccurate
assessment of related cumulative impacts. Therefore, this MD EJSCREEN 4.0 proposal aims to close these
gaps through the following specific aims: Specific Aim #1: Apply novel monitoring and modeling approaches
to assess inequities in exposure to air pollution (PM10, PM2.5, PM1, O3, NO2) and health outcomes. Specific
Aim #2: Utilize advanced statistical analyses and iterative stakeholder engagement (focus groups and
interviews) to better characterize and capture drivers of environmental injustice and cumulative impacts within
MD EJSCREEN. Specific Aim #3: Assess the association between drivers of environmental injustice,
cumulative impacts, environmental health disparities through MD EJSCREEN 4.0 and MD EJSCREEN 3.0.
This MD EJSCREEN 4.0 project is aligned with the NIEHS's strategic plan to advance innovative development
of new measures, and validate and adapt existing measures and approaches to address exposome-related
factors that contribute to or exacerbate environmental health disparities. The proposed project is innovative
because we will include the use of mixed methods approaches, real-time air quality data, SRD measures,
climate indicators, and advanced biostatistical and geostatistical approaches in building MD EJSCREEN 4.0.
We expect that this updated tool to act as a model for other national and state-level EJSM tools.

Public health relevance
Project Narrative Across the state of Maryland, communities of color and low wealth populations are differentially burdened by environmental hazards and the cumulative impacts of chemical and non-chemical stressors and structural factors including pathogenic infrastructure that produce environmental health disparities (i.e., environmental injustice). To better identify and characterize environmental justice (EJ) communities, we plan to update Maryland Environmental Justice Screen (MD EJSCREEN), an environmental justice screening and mapping (EJSM) tool by the integration of air quality data and use of mixed methods approach- stakeholder feedback through focus groups and interviews and advanced statistical and geostatistical methods. This project is relevant to public health because it may: (1) help track disparities in air pollution exposure; (2) improve our capacity to track cumulative impacts of chemical and non-chemical stressors; (3) better visualize and track exposure-disease associations including health disparities at the neighborhood level; and (4) assist with microtargeting high risk areas that need mitigation strategies and investments to eliminate environmental injustice and improve public health.